Career Enhancement Core

ABSTRACT: CAREER ENHANCEMENT CORE
The overall goal of the Career Enhancement Core at Yale Center for the Study of Tobacco Product Use and
Addiction (YCSTP) is to train the next generation of multidisciplinary, independent scientists in Tobacco
Regulatory Science. Under TCORS 3.0, the Core will continue to support the careers of post-doctoral
associates and junior faculty motivated to become Tobacco Regulatory Science (TRS) investigators
and support the career enhancement of established investigators who seek to pursue new areas of
research. The Core will accomplish its goal by leveraging the successful training program developed in
TCORS 1.0 and 2.0. Specifically, the Core will 1) select and appoint Scholars for a specialized career
enhancement program in TRS; 2) provide didactic and experiential training on FDA regulation of tobacco
products and TRS research, 3) invite speakers who are experts in TRS to enhance knowledge in timely and
impactful TRS research and stimulate new interdisciplinary collaborations, 4) provide opportunities for scientific
exchange through small travel grants to learn new methods, foster collaboration, and attend TRS and other
scientific conferences, and 5) provide pilot research grants to stimulate novel research that addresses the
FDA’s research priorities. The pilot grants will be available to Scholars, new researchers in TRS, or TRS
researchers extending their research to novel areas, to stimulate research innovations. The Career
Enhancement Core will provide a mechanism for review, funding, and ongoing oversight of pilot projects. All
funded projects will receive assistance from the Laboratory Core, Administrative Core, and Measurement and
Analytic Core to achieve their objectives. Through its services, the Career Enhancement Core will support the
careers of new TRS researchers and stimulate TRS science to advance our scientific understanding of nicotine
and flavors in tobacco products and support FDA’s regulatory authority.